Testing Strategies for Couple Engagement in PMTCT and Family Health in Kenya

This is an application for an administrative supplement to a current NIMH R01 study that was severely affected
by the COVID-19 pandemic. Despite the potential for antiretroviral therapy to improve maternal health and
reduce mother-to-child transmission of HIV to as low as 1%, HIV-related maternal deaths and HIV infection
among infants remain unacceptably high across sub-Saharan Africa. This is particularly true in Kenya, where
crucial drop-offs occur in the cascade of prevention of mother-to-child transmission (PMTCT) services. Weak
health systems contribute to insufficient service coverage, but many barriers lie beyond the clinic—in the partner,
family, and community factors that shape women’s health decisions. Our team’s research in a high HIV
prevalence area of southwestern Kenya has shown that many women avoid couples HIV testing and do not
adhere to PMTCT regimens because they fear negative consequences from a male partner. Men can play a
crucial supportive role for family health, but male partners in Kenya are poorly engaged in antenatal care and
uptake of couples HIV testing during pregnancy is low. Pregnant women desire to be tested for HIV together
with their partner and need the support for mutual disclosure involved in couples HIV testing and counseling
(CHTC), regardless of whether they know their own HIV status. In this context, we are testing the efficacy of an
interdependence theory-based couples intervention that reaches pregnant women and male partners through
home visits by male-female pairs of lay health workers, and includes offer of home-based CHTC services. We
are conducting a robust investigation to determine whether this intervention improves uptake of couples HIV
testing and health outcomes over and above less intensive male engagement strategies being used in the region.
We are conducting a three-arm trial among 800 pregnant women and partners, randomizing them to home-
based couple visits, HIV self-test (HIVST) kits to use with their male partner, or standard care, following couples
up to 18 months postpartum. In Aim 1, we are determining the effects of the intervention on our primary outcome
of couple HIV testing, compared to HIVST kits and standard care. In Aim 2, we are examining intervention impact
on HIV prevention behaviors, facility delivery, and postnatal healthcare utilization. Among couples living with
HIV, secondary outcomes include maternal VL suppression and HIV-free child survival up to 18 months. In Aim
3, we are comparing the cost-effectiveness of the home-based couples intervention to the less resource-
intensive strategies used in the other two study arms. Due to restrictions on in-person research posed by the
COVID-19 pandemic we completed enrollment of 800 couples more than one year later than planned, and will
not be able to complete intervention delivery and follow-up of the sample with the originally allocated time frame
and funds. This administrative supplement is necessary to be able to achieve the aims of our study and inform
decision-makers about cost-effective strategies to engage pregnant couples in PMTCT and family health, with
important downstream benefits for maternal, paternal, and infant health.

Public health relevance
Project Narrative This research will contribute to public health efforts to improve the health of pregnant women, their male partners, and infants in low-resource settings by examining the efficacy and cost-effectiveness of a home-based intervention to increase couple HIV testing and counseling and mutual disclosure, which engages both members of the couple in support of family health and will have important implications for uptake of HIV prevention and treatment, as well as for maternal, paternal, and child health. We are requesting an administrative supplement in order to be able to complete intervention delivery and follow-up assessments for this study, which was severely impacted by the COVID-19 pandemic. This research has the potential to make important contributions towards reducing some of the most significant public health problems in sub-Saharan Africa, including mother-to-child transmission of HIV; maternal, paternal, and infant mortality; and transmission of HIV in serodiscordant couples.